Health and Aging Brain among Latino Elders (HABLE-AT(N)) Study

PROJECT SUMMARY
The 2018 NIA - Alzheimer's Association Research Framework [AT(N)] for Alzheimer's Disease (AD) provides a
biological context for studying AD by incorporating state-of-the art biomarkers of amyloid (A), tau (T) and
neurodegeneration (N). Despite the fact that these biomarkers vary by race/ethnicity, no prior work has
systematically examined them among Mexican Americans. Given that (1) Hispanic/Latinos are projected to
experience the largest growth in AD and Alzheimer's Disease Related Dementias (ADRDs) by 2060 and (2)
Mexican Americans are the largest segment of the U.S. Hispanic/Latino population, there is a pressing need to
study prevalence, progression and clinical impact of these biomarkers among this underrepresented group.
This work addresses goals of the National Alzheimer's Project Act (NAPA), NIA Milestones for AD and ADRD
research, and needs highlighted by the AT(N) framework publication.
The current research team consists of leading experts in Mexican American cognitive aging, neuroimaging
(PET and MRI), blood-based biomarkers as well as advanced statistical modeling. By leveraging the ongoing
HABLE cohort, infrastructure and data, we will test the following Specific Aims: Aim 1: Examine the
prevalence, progression and clinical impact of cerebral markers of the 2018 AT(N) framework among
community-dwelling Mexican Americans. Aim 2. Examine the prevalence, progression and clinical impact of
blood markers of the 2018 AT(N) framework among community-dwelling Mexican Americans. Aim 3: To
determine if blood-based biomarkers of Aβ40, Aβ42, tau and NfL can be used to screen for AT(N)-defined
preclinical AD, prodromal AD and AD dementia for enrollment of Mexican Americans into novel clinical trials.
The current study is highly significant for several reasons: (1) This is the first-ever large-scale multi-ethnic
study of the AT(N) biomarkers, which is of tremendous importance given the racial/ethnic make-up of the U.S.
population; (2) this work directly addresses goals set forth by NAPA as well NIA-Milestones for AD/ADRD
science; (3) it will determine if ethnic-specific biomarker trajectories are appropriate and finally, (4) it will
generate data and methods for increasing enrollment of Hispanics into clinical trials across the AT(N)-defined
spectrum of AD (primary, secondary and tertiary prevention) beginning in primary care settings.

Public health relevance
PROJECT NARRATIVE The 2018 AT(N) Framework provides a biologically-based context for studying AD with recent work demonstrating that these core biomarkers vary by race/ethnicity. This study will examine both PET-based and blood-based biomarkers of amyloid (A), tau (T) and neurodegeneration (N) at baseline and follow-up examinations. The information gained will (1) provide data to determine if the 2018 AT(N) Framework requires ethnic adjustments, (2) create a multi-tiered system that can be deployed in primary care settings to screen Mexican Americans with blood-based tools into novel trials and (3) provide methods and data to support ethnically-appropriate tailored novel clinical trials aimed at treating and preventing AD among this underserved population.